Mechanisms of photoreceptor specification and morphogenesis

PROJECT SUMMARY
Despite our dependency upon cone-mediated vision, and the debilitating impact of cone
degeneration upon our central vision, major gaps exist in our knowledge of genes and
mechanisms that regulate the number and spatial patterning of photoreceptors. Underlying this
asymmetry is the fundamental choice of retinal neuroblasts to re-enter mitosis or differentiate.
The larval zebrafish retina provides an unparalleled genetic model to identify fundamental
mechanisms integrating photoreceptor specification and spatial patterning. The larval zebrafish
retina is anatomically and functionally cone-dominated with 4 cone subtypes arranged in a
highly ordered mosaic. Rods are far less numerous and distributed asymmetrically along the
dorsal/ventral axis. The range of genetic tools, availability of genomic resources and access to
the zebrafish embryo, permit a systematic approach to uncover the impact of genetic
manipulations upon cell fate and their distribution. Our premise is based upon rigorous genetic
and molecular analysis in our published studies and preliminary data showing that tbx2b/lor and
six7/ljr are essential for maintaining the cone-dominated zebrafish retina. Mutations of tbx2b
result in a 5-fold increase and uniform distribution of rods due to a cell fate switch of SWS1-
cones into rods, a phenotype opposite to that of the rd7 mouse and enhanced-S cone syndrome
in humans. Mutations of six7, an orthologue of Six3/6 result in a similar increase and uniform
distribution of rods, however characterization of several alleles revealed that six7 independently
suppresses mitosis of late stage progenitors, and is essential for survival of a cone subtype. Our
goal is to understand the mechanisms underlying functions of tbx2b and six7 in cell fate
decisions and spatial patterning in the context of know factors that regulate photoreceptor
development. Aim 1 will take advantage of innovative genome editing tools, transposon-based
transgenesis, and more routine methods to test the hypothesis that six7 modulates the choice of
late stage photoreceptor progenitors between continued mitosis or differentiation. Aim 2
combined in vivo and in vitro approaches to test our novel hypothesis that tbx2b regulates the
timing of photoreceptor determination and thereby spatial patterning through molecular
interaction with known photoreceptor transcription factors. Furthermore, our unpublished data
and published reports show unexpected alterations in gene expression following genetic
alterations suggesting unrecognized roles for these factors in maintaining cell fate. Therefore,
completion of the specific aims will significantly advance the fields knowledge of mechanisms
regulating the generation of a highly specialized, cone-dominated retina.

Public health relevance
PROJECT NARRATIVE Our high acuity, day light vision is dependent upon the high density of cone photoreceptors located in specialized regions of the retina called the fovea and the surrounding macula. Cone density falls to just 5% of the photoreceptors in the retinal periphery, yet despite the significance of the asymmetric distribution, little is known of the mechanisms that regulate spatial pattering of photoreceptors in any vertebrate species. We will take advantage of the cone-dominated zebrafish as a tractable model system to test novel mechanism regulating specification and patterning, and the principles uncovered will be applicable to the human retina and other neural systems.